Center for Population Health and Aging

Overall
PROJECT SUMMARY/ABSTRACT
The Duke Center for Population Health and Aging (CPHA) will continue to support an
interdisciplinary environment to develop faculty in aging research and to foster important
scientific scholarship within our three themes, which include (1) the biodemography and
biosocial demography of aging, (2) social disparities in health and well-being across the life
span, and (3) intergenerational consequences and transmission of health and longevity. CPHA
activities will be supported by an infrastructure consisting of four integrated cores: (A) a strong
Administrative and Research Support Core that provides central clerical, technical, event
planning and research support services including pre- and post-award grants and project
management; (B) a Development Core that sponsors (i) a peer-reviewed pilot research program
and an accompanying mentorship program designed to assist emerging scholars in obtaining
extramural funding for innovative and important topics, (ii) a seminar series that brings invited
experts from around the world to present their research and interact with students, post-doctoral
scholars, and faculty scholars of the center, (iii) a monthly student seminar in which graduate
students at all stages, postdoctoral scholars, and junior faculty receiving pilots present their
work and are offered feedback from CPHA associates, and (iv) regular computational and
statistical training workshops for students and faculty affiliates; (C) a Communications and
Dissemination Core that coordinates all aspects of announcing and reporting on CPHA activities
to CPHA associates, internal Duke units and administrators, the scientific community, the P30
Coordinating Center, the Association of Population Centers, the NIA, and the public; and (D) an
External Network Core that maintains and expands a network of scholars throughout North
Carolina, the region and beyond whose focus is on rural health disparities.

Public health relevance
Project Narrative (Overall) The Duke Center for Population Health and Aging (CPHA) supports rigorous and innovative research in biodemography/biosocial demography, life course studies of health disparities, and intergenerational transmission of inequality and health to understand the relationship between social and biological factors in healthy aging and longevity, to support and enlarge the community of demographers working in population health, and to both disseminate research findings to the larger community and accelerate the transfer of research to practice.